Cardiovascular Epigenetics and Gene Regulation

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Cardiovascular Epigenetics and Gene
Regulation, organized by Drs. Roger Foo, Federica Accornero and Enzo Porrello. The conference will be held
in Hannover, Germany from April 15–18, 2024.
Cardiovascular disease (CVD) can unexpectedly reduce the life expectancy among young, healthy adults and
can also cause debilitating, chronic conditions later in life, presenting a concerning health impact in our aging
population. Further, it is a significant cause of death worldwide, claiming the lives of 17.9 million annually. As a
result, there is an ongoing need to reduce the impact of CVD through basic and translational research. In parallel,
emerging discoveries in epigenetics and epitranscriptomics have defined gene regulatory circuits—enforced by
chromatin or nucleic acid modifications and the enzymes that maintain them—that modulate cellular states.
These pathways, when perturbed, have demonstrated links to numerous diseases. While several epigenetic
targets have shown promise in cancer, emerging research in myocardial cells and cardiovascular systems has
hinted that these gene regulatory pathways may offer new therapeutic opportunities for combatting CVD. This
Keystone Symposia conference was designed to unite investigators from across the vascular and cardiac fields
with researchers focused on understanding epigenetic and epitranscriptomic regulatory mechanisms. The
program focuses on mechanisms of CVD pathophysiology and potential links to gene expression pathways and
explores how known CVD-linked factors (metabolism, inflammation, etc.) might tie into epigenetic regulation in
cardiovascular systems. This conference will offer a unique opportunity to bring together two divergent groups
of researchers to explore the connections between CVD and epigenetic and epitranscriptomic regulatory
mechanisms with an aim to define potentially new therapeutic approaches in this area.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is a significant cause of death worldwide, claiming the lives of 17.9 million people annually. By bringing together key opinion leaders in the cardiac and vascular epigenetics communities, as well as external experts in other related fields such as systems genetics, this conference creates a unique opportunity to cross traditional disciplinary boundaries in the cardiovascular field. This will be the first time that this group has come together for a meeting and creates an opportunity to forge new collaborations and to initiate crosstalk in the growing field of cardiovascular epigenetics and gene regulation.